Assessment of approach-avoidance motivation in neuropsychiatric disorders

ABSTRACT
PAR-18-30 “Development and Optimization of Tasks and Measures for Functional Domains of Behavior”
encourages research projects that will develop and optimize new or existing tasks and measures for the
Research Domain Criteria (RDoC). This call stems from workgroups of the National Advisory Mental Health
Council that identified significant gaps in the RDoC measurement toolkit. In the negative valence systems (NVS)
domain, one priority area is the need for behavioral paradigms for identifying areas of overlap and distinction
between NVS, which motivate defensive avoidance behaviors, and positive valence systems (PVS),
which motivate reward-approach behaviors. We contend that approach-avoidance (AP-AV) paradigms
offer a promising solution. AP-AV tasks are essentially behavioral approach tests that enable assessment
of overt behavioral responses to acute threats. The aims of this proposal are to demonstrate the (1)
psychometric adequacy (test-retest reliability) and (2) diagnostic/predictive validity of a user-friendly
instructed AP-AV-task we’ve developed for assessing psychosocial dysfunction associated with anxiety,
depression, psychosis, and other conditions. Our aims build upon extensive preliminary research in our
lab devoted to optimizing task parameters, measures and administration. This work has the potential to
yield an easy-to-use and widely disseminable AP-AV task for identifying areas of overlap and distinction
between NVS and PVS, as well as a general AP-AV methodology that is adaptable for assessing overt
behavioral responses to acute threats. To achieve these aims, we will recruit three matched groups of adults
(healthy, elevated social anxiety, and elevated social anhedonia). Inclusion of groups with anxiety and
anhedonia are necessary to assess diagnostic and predictive validity. Participants will complete
standardized clinical assessments and complete the instructed AP-AV task multiple times during two
neuroimaging sessions, separated by 10-14 days. Between imaging sessions, ecological momentary
assessments (EMA) will capture mood, motivational level, frequency of real-life approach/avoidance,
and emotional regulation strategy use. This research is theoretically significant because it highlights the
relevance of theories of AP-AV motivation for research devoted to identifying areas of overlap and distinction
between NVS and PVS. This research is methodologically innovative because it will produce a user-friendly
AP-AV task with strong psychometric properties for use in behavioral (stand-alone) or neuroimaging
research. Outcome data will also provide the necessary empirical foundation for future investigations into the
suitability of AP-AV tasks for use with individuals who vary widely in age, ability, and/or severity of disorder.

Public health relevance
NARRATIVE The lack of valid and reliable RDoC behavioral tasks and measures for identifying areas of overlap and distinction between negative and positive motivational systems in the human brain represents a significant barrier to public health research on a variety of neuropsychiatric disorders. The long-term goal of this project is to demonstrate the psychometric strength and the diagnostic and predictive validity of a user-friendly AP-AV task that we’ve developed for use in behavioral and neuroimaging research. Outcomes of this project include a flexible paradigm for immediate use in human research, and empirical data that lay the foundation for future investigations into the paradigm’s suitability for use with individuals who vary widely in age, ability, and/or severity of distress and/or dysfunction.